Administrative Unit

The Center will take advantage of the extensive experience of the administrative staff of the Institute for NanoBioTechnology (INBT), where the Center will be housed, to coordinate the research and educational programs of the Center. Therefore, we have already identified the administrative staff of the Center. The Center grant will support 75% of an Administrator (Susannah Porterfield), 25% of the Web Director (Martin Rietveld), 25% of the Training Program Coordinator (Ashanti Edwards), and 25% of the Media Relations Director (Man/ Spiro). and 5% of the Director of Corporate Partnership (Tom Fekete). This administrative staff has extensive experience in the redaction of annual progress reports, organizing site visits, creating press releases and newsletter for outreach activities, organizing multidisciplinary symposia and workshops, coordinating training programs, managing research grant accounts, etc. The administrative staff of the Center will meet with the Center co-Directors once a week (see Section N3 under Organization of the Leadership Structure of the Center). The Center Administrator will have daily meeting with the Center Director.